The role of the brain stem in GWVI pathology

Gulf War Veterans’ Illness (GWVI) is characterized by multiple chronic symptoms including wide-spread pain
and sleep disturbances. This project will focus on brainstem structures and white matter pathways that
specifically link the hypothalamus, periaqueductal gray and locus coeruleus (along the hypothalamic-pituitary-
adrenal axis), and investigate their role in modulating pain and sleep disturbances associated with GWVI. We
hypothesize that GWVI is associated with damage of specific brainstem white matter circuits and nuclei known
to modulate pain signaling and sleep-wake cycles resulting in dysregulation of these critical functions. We
propose state-of-the-art brain imaging techniques to assess the brainstem fiber integrity and volume changes
of key brainstem nuclei and correlate these imaging measures with GWVI-related pain and sleep measures,
specifically. To test the novel hypothesis of pain modulation deficits in GWVI, we will additionally use
conditioned pain modulation (CPM) to evaluate the efficacy of descending pain modulation stimulated by a
noxious peripheral stimulus. The translation of our findings into new therapeutic trials is very probable given
that there are several novel candidate interventions that would allow the targeting of these brainstem
structures.
Our hypotheses will be tested in an observational study comparing 50 GWVI Veterans and 50 non-
symptomatic Gulf War era (GWE) Veterans. After screening, confirmation of eligibility, and consenting all
Veterans will undergo a 2-day assessment. Day 1 will comprise a battery of cognitive / functional tests and a
conditioned pain modulation (CPM) test. On Day 2, MRI exams will be performed on each patient and the
remaining cognitive/functional testing will be completed. Both visits will be no more than one week apart. This
4-year proposal will include 100 participants (2 groups of 50 each) with outcome measures collected at
appropriate time points.

Public health relevance
About 30% of Veterans who served in the 1990-91 Persian Gulf War are suffering from Gulf War Veterans’ Illness (GWVI), a chronic condition that is still not well understood and for which adequate treatment is lacking. GWVI is manifested by multiple chronic symptoms, including pain, sleep, neurological, gastrointestinal, respiratory, and skin problems. Recent evidence suggests that the brainstem is selectively damaged in GWVI. Novel brain imaging techniques enable us now to objectively measure this damage and to relate it to GWVI symptoms. We propose to investigate the role of the brainstem in regulating pain and sleep in GWI using advanced brain imaging and psychophysical measurements. The findings from this project have great potential for the development and refinement of novel therapeutic approaches using drugs, psychotherapy or neurostimulation to target and augment descending modulation pathways.